University of Michigan Anesthesiology Post-Doctoral Research Training Program

PROJECT SUMMARY / ABSTRACT
The University of Michigan (U-M) is one of the largest and most highly ranked public universities in the country
as well as a major center for graduate and post-graduate research training. The Ann Arbor campus is home to
19 schools and colleges, and U-M faculty and students embrace multidisciplinary training and research. With
almost $1.5B in annual research expenditures, U-M is the top public university in research spending in the
United States; more than half a billion of annual awards go to the Medical School. Within this broader
environment of excellence, the U-M Department of Anesthesiology has reached an unprecedented level of
research success, as evidenced by increased NIH awards (current #1 ranking for anesthesiology departments)
and other sources of funding; increased quantity and quality of publications; high-level institutional research
roles; and national research leadership in fields (such as precision medicine and translational science) that
transcend traditional boundaries of the field. The department has a created a supportive and nurturing
environment for developing the research workforce and the anesthesiology T32 training program has become
the centerpiece of our career development program. Our first T32 graduates are active academic
anesthesiologists leading multidisciplinary research teams, with continued support and mentorship from senior
faculty members. Their success in high-level publications and NIH grant applications suggests a positive
impact of our T32 program. In the next phase, we hope to enhance professional growth through stronger
partnership with our institutional CTSA program and its Career Development Academy, develop more effective
mentors through formal training, leverage our institutional and national roles to connect T32 fellows to expert
perspectives from different fields and different institutions, and enhance the diversity of our applicants and
trainees. We are deeply committed to helping diverse clinician-scientists become ethical and outstanding
researchers, leaders in their field, committed mentors, and change agents who contribute to the public good
through a positive impact on medicine, science, and society.

Public health relevance
PROJECT NARRATIVE The University of Michigan T32 postdoctoral training program in anesthesiology will benefit public health by developing a diverse and ethical research workforce that addresses health problems related to surgical care, critical care, and pain management, as well as the science that underlies it.